Research and Education Core

ABSTRACT – RESEARCH EDUCATION CORE
Disparities in health care based on race/ethnicity represent a mutable factor that costs the U.S. government
billions of dollars annually. According to the National Academy of Science Board on Higher Education, Blacks,
Latinos and Native American tribal people together represent approximately 25% of the nation’s populations, yet
they represent only 8% of the total science and engineering PhD recipients. The Florida-California Cancer
Research, Education & Engagement (CaRE2) Health Equity Center, is a collaboration among Florida A&M
University (FAMU, a Historically Black College and University {HBCU}), University of Florida (UF) and University
of Southern California (USC) that will advance cancer research to better meet the needs of Black and Latino
communities. In response to the Comprehensive Partnerships to Advance Cancer Health Equity (CPACHE) U54
PAR, the CaRE2 Health Equity Center Research Education Core (REC) is proposed to meet the cancer
research education needs of underrepresented minorities (URM) in Florida and California, especially Blacks and
Latinos. The REC will: (1) support the training of 30 URM post-bac students in a one-year mentored research
and training program (“Postbac-CaRE2”); and (2) provide academic career development, mentorship, and tailored
research training opportunities to increase the competitive research capacity for a total of 90 URM graduate
students, post-doctoral fellows and early-stage investigators and 40 ongoing trainees(CaRE2-Grad+); (3)
Evaluation of CaRE2 Research Education activities. Post-baccalaureate trainees at each partner site will have
a year-long immersion in research, working with multidisciplinary teams to build their knowledge of research and
to promote their academic career paths in cancer-related health disparities. Graduate students, post-doctoral
fellows and ESIs at each site will receive intensive mentoring, academic career development and tailored
research training opportunities to promote their successful attainment of research-related and academic
milestones. Program outcomes of the REC will be monitored with Planning and Evaluation Core support to
develop a robust long-term tracking and evaluation program of the REC activities across the diverse CaRE2
training pipelines. The Administrative Core will use data gathered via assessment activities to implement
program changes as needed to promote the success of the trainees.